COMPASS: A Family-Centered, Culturally Responsive Conversational AI Assistant to Support ADRD Caregivers and Family Care Networks in Real-Time

Project Summary
The majority of people living with dementia (PLWD) in the U.S. are cared for at home by family or friends
without formal training. The challenges of providing ADRD care, dealing with challenging ADRD behaviors,
and coordinating with the family care network causes significant mental, physical, and emotional burden for
caregivers, especially for minoritized ADRD caregivers who face additional adverse health outcomes and
cultural barriers in accessing support. Commercial solutions are not scalable for affordable use (i.e., remote
care with ADRD experts) or lack personalization and cultural responsiveness (i.e., mobile or web -based
caregiver apps with “generic” information). Support groups pose scheduling, geographic, and stigma barriers
and do not offer real-time expert feedback or evidence-based skills. Without 24/7 expert support, caregivers
are left to search through the Internet for “generic” solutions. There is a significant unmet need for culturally
relevant, accessible, and scalable personalized ADRD caregiving guidance and coordination support to
address the real-time needs of diverse ADRD caregivers, PLWD, and families. We are developing a family-
centered, conversational AI assistant called COMPASS to support ADRD caregivers in real-time with 1)
personalized, culturally relevant ADRD caregiving guidance and 2) assistive coordination within their family
care network. Our novel technology leverages advances in culturally responsive AI to understand diverse
caregiver queries and personalize responses and delivery to each caregiver and PLWD’s personal/cultural
context. A virtual avatar tailored to the caregiver’s preferences will be used to communicate guidance in areas
consistent with existing and validated multicomponent ADRD care interventions to assist with the daily
challenges of ADRD caregiving and communication within the family care network. With caregiver approval,
COMPASS can help share actionable information to family members in the network. In Phase 1, our 12-month
goals are to develop a prototype of COMPASS and test its initial usability/feasibility for racially and ethnically
diverse AD/ADRD family caregivers. By providing real-time support and building a care community, COMPASS
aligns with the NIA’s goals to improve access and adherence to evidence-based caregiving support while
reducing caregiver burden and enabling effective care for the PLWD.

Public health relevance
Project Narrative As the number of people living with dementia is expected to double to 13.8 million by 2060, the strain on dementia family caregivers will be further intensified, especially for minoritized caregivers who are affected disproportionately and face cultural barriers in accessing support. This project aims to develop a family- centered, culturally responsive AI-enabled conversational assistant to support ADRD caregivers in real-time with 1) personalized, culturally relevant ADRD caregiving guidance and 2) a coordination capability within their family care network. Successful completion will support the development of a novel, real-time multicomponent intervention delivery for AD/ADRD caregivers and their family that addresses a significant market gap to increase health equity.